Modulation of nociception in the hornworm, Manduca sexta

Project Summary Nociception is the sensory reception and processing of noxious stimuli, which is perceived as pain in humans. Nociceptive sensitization occurs after presentation of a noxious stimulus, and in humans can result in chronic conditions such as allodynia or hyperalgesia, where normally innocuous stimuli are perceived as painful. It has been suggested that nociceptive sensitization in invertebrates may be models of allodynia or hyperalgesia, and this project aims to use the defensive strike response in the hornworm Manduca sexta as a model of allodynia and hyperalgesia. As an invertebrate, M. sexta is unregulated, has a simple nervous system that can be maintained with minimal aeration in vitro for hours to days, and has a quantifiable defensive strike in vivo. Moreover, vertebrate pain signaling molecules appear to have homologous counterparts in insects. The goals of this project are to: 1) Characterize nociceptive sensitization in M. sexta, in terms of the duration of the response and the types of stimuli inducing sensitization. 2) Identify the sensory network and nociceptors in M. sexta electrophysiologically and immunohistochemically, and 3) Verify the molecular mechanism of sensitization and analgesia.

Public health relevance
Narrative Chronic pain can arise from tissue damage and inflammation, leading to conditions such as allodynia and hyperalgesia. Much still needs to be understood regarding the mechanisms leading to these conditions and in alleviating them. The use of insects for pain research alleviates many ethical issues and constraints of animal protocols, and thus has the potential for use in developing pharmaceuticals in vertebrates